Chemical Biology of Cell Division

Project Summary/Abstract
The long-term goal of our research is to decipher the essential molecular mechanisms underlying successful cell
division. Errors in this process have been linked to developmental defects and diseases such as cancer. We
now know essentially every protein needed for cell division. However, analyzing the precise molecular
mechanisms needed for error-free division has continued to be very challenging for at least three reasons. First,
cell division in human cells is a highly dynamic process that can be completed in <1 hour, with key steps such
as chromosome-microtubule attachments and nuclear envelop reformation taking only a few minutes. Second,
the microtubule-based structures that dynamically self-assemble and function in dividing cells can be ~1000-
times larger than their nanometer-sized protein components. Third, this multi-step process depends on several
distinct protein-protein interactions that can be transient and mitosis-specific. To address these challenges and
fill gaps in our knowledge we have: (i) Discovered and characterized cell-permeable chemical inhibitors of key
mechanoenzymes (e.g. AAA, ATPases associated with diverse cell processes). These chemical probes can be
used to rapidly (typically, within minutes) inhibit or activate (through relief from inhibition) protein function in
dividing human cells. We combine these fast perturbations with state-of-the-art microscopy (e.g. lattice light-
sheet microscopy) and quantitative image analysis to dissect mechanisms underlying cell division dynamics in
human cells. To identify target-specific phenotypes we carry out parallel inhibitor dose-dependent analyses in
matched cell lines that are either inhibitor-sensitive or -resistant. (ii) Deciphered how micrometer-sized features
(e.g. microtubule length or overlap length) can effectively be measured by nanometer-sized proteins to generate
proportionate outputs (e.g. tags or force). For these studies we have generated a biochemical ‘toolbox’
comprised of recombinant forms of the augmin complex, isotypically-pure human tubulin, key microtubule-
associated motor and non-motor proteins and g-TuRC (g -tubulin ring complex), the major microtubule nucleator
in human cells. (iii) Developed and applied chemical proteomics approaches to ‘capture’ and profile direct,
transient and context-dependent protein-protein interactions in living cells. The research proposed benefits from
our expertise and will combine chemical, structural and cell biology approaches to answer long-standing
questions, including: (a) What are the functions of different AAA mechanoenzymes during cell division and how
are their activities regulated? (b) What is the structural basis of g-TuRC-dependent microtubule nucleation and
how does this complex contribute to centrosome-dependent and -independent microtubule formation during
mitosis? Our research should provide new insights into fundamental mechanisms, uncover general principles
that inform on other cellular processes (e.g. microtubule organization in neurons), and may provide starting
points for developing new therapeutics.

Public health relevance
Project Narrative Errors in cell division have been linked to developmental defects and disease in humans. We take inter- disciplinary approaches to decipher the molecular mechanisms required for accurate cell division. Our findings have the potential to facilitate the development of new therapeutic strategies based on targeting cell division and the cytoskeleton.